Molecular Regulators of Renal Collecting Duct Differentiation and Maintenance

PROJECT SUMMARY:
It is critical to understand the cellular and molecular mechanisms regulating water and ion homeostasis, as
imbalances in these are frequently associated with kidney disease. While mutations in ion and water channels
and in regulators of these channels, result in congenital forms of fluid and electrolyte disorders, the cellular and
molecular basis of acquired forms of fluid and electrolyte imbalances are less clear. Changes in ratios of kidney
epithelial cell types within distal nephron and collecting duct (CD) segments, composed of diverse intermingled
principal and intercalated cell types, have been correlated with the occurrence of water and electrolyte disorders.
For example, lithium treatment of patients with bipolar disorder triggers an acquired form of nephrogenic diabetes
insipidus (NDI), involving an inability to sufficiently reabsorb water, along with a decrease in ratio of principal
cells (PCs) to intercalated cells (ICs). To understand the relationship of cell type changes to water and ion
homeostasis we have identified that Notch1&2 signaling via Hes1 is required for maintaining Aquaporin-2 (Aqp2)
expressing PCs in the distal nephron, and CD segments of adult mouse kidneys, without which the PCs are
replaced with ICs. We identified Elf5 to be a PC specific marker downstream of Notch signaling and used Elf5-
lineage tracing mice to monitor the fate of mature PCs in adult kidneys. Interestingly, either inhibition of Notch
signaling or short-term lithium treatment promotes mature PCs to convert into ICs. Here we propose to test the
hypothesis that PC to IC conversion contributes to water reabsorption defect in acquired NDI, while IC to PC
conversion are important in the recovery from NDI. The overarching novel hypothesis is that Notch1&2 via Hes1
regulate water and ion homeostasis in PCs by directly regulating expression and/or function of water and ion
channels independent of preventing PCs to switch into ICs. However, in response to certain diets or mediations
Notch signaling is pathologically suppressed and triggers PC to IC conversions resulting in NDI. To test this
hypothesis and to understand the mechanisms by which PC to IC conversions occur, and importance of PC to
IC conversions to acquired forms of NDI we propose three specific aims. In Specific Aim1, we ask how Hes1
does suppress the IC program from turning on in adult PCs? In this aim we will examine the mechanisms
regulating PC to IC conversions. In Specific Aim2 we will identify mechanisms, independent of suppressing
Foxi1, by which Notch signaling contributes to PC functions. This will test whether Notch signaling is part of the
principal cell signaling network that responds to physiologic stimuli such as aldosterone, and hyperosmolality. In
specific aim 3 we will determine if acquired NDI involves PC to IC conversions and test if IC to PC conversions
are part of the regenerative capacity of the kidney to recover from NDI.

Public health relevance
PROJECT NARRATIVE: These studies will uncover the molecular mechanisms by which the kidney collecting duct principal cell (PC) types are converted to intercalated cell (IC) types. Also, these studies will reveal if PC to IC conversions are an underlying cause of acquired forms of nephrogenic diabetes insipidus (NDI), and if the reverse IC to PC conversion is part of the regenerative capacity of the kidney to recover from acquired NDI. The knowledge gained about the mechanisms by which adult kidney epithelial cells convert from one type to another is likely of value in understanding disease states in other adult organs in which Notch signaling also regulates cell type conversions, such as in the lung.